Center for Medical Genomics

ABSTRACT, Genomics Core (GC)
With the sequencing of the human genome, biomedical sciences have entered the age of functional genomics.
New technologies offer the promise of vastly increased understanding of biology, and through that of better
approaches to the prevention and treatment of complex disease, including cancer. Next-generation sequencing
(NGS) of DNA and RNA has become a powerful tool for genomics study. It allows detection and identification of
known as well as novel variations at base level. It measures gene expression, allele-specific expression,
epigenomic changes, and alternative splicing of whole transcriptome. Microarray technology is also powerful for
experiments involving known gene elements. SNP genotyping allows confirmation of variations discovered in
NGS. These state-of-the-art technologies provide comprehensive approaches for functional genomics in cancer
research. Studies based on these genomic tools, both in humans and in model organisms, will lead cancer
treatment into an era of more individualized treatments.
The Genomics Core (GC) at Indiana University School of Medicine (IUSM) provides state-of-the-art genomics
services to investigators at Indiana University Simon Cancer Center (IUSCC), including next generation
sequencing, single-cell analytics, microarray and high-throughput genotyping. With decades of experience and
strong track record in supporting cancer research, significant subsidization from IUSM and IUSCC, and strong
ties with the Center for Computational Biology and Bioinformatics (CCBB), the GC strives to provide IUSCC
members high-quality genomic services with fast-turnaround times at affordable prices.